Uncovering the Invisible Risks for Suicide: Nationally Representative Samples of Youth in Guyana

Rates of suicide among the young have been rising globally for decades. Despite research advances,
suicide is now the second leading cause of death worldwide for those 15-29, clearly a global public health crisis.
Importantly, improved prevention and intervention depend on development of innovative research approaches
that overcome the challenges of existing research and that can lead to a broader and deeper understanding of
the yet unidentified risk factors. We call these “invisible risks”. As LMICs represent 80% of the worldwide suicides,
they are an important target for suicide prevention efforts. The risk factors for youth suicide in LMICs are
especially poorly understood, in part due to the logistics of conducting epidemiologic research in LMICs, and in
part because suicide research has its own well-known challenges, regardless of where it’s conducted.
This proposed study of youth suicide, including its trajectories and risk factors, will take advantage of the
special circumstances of Guyana, the country with the second highest rate of both adult and youth suicides in
the world, and a Ministry of Health committed to suicide prevention and actively cooperating with our team to
investigate adult suicide. Guyana has notable heterogeneity in ethnicity, race, religion and economic class,
making it an important model country for suicide research. In addition, this proposed study will leverage the
human, intellectual, and administrative infrastructure developed for our ongoing NIMH funded Guyana Well-
Being Study. Taken together these factors make Guyana a well-suited site for the goals of this study, including
examining factors that have often been ignored or misclassified, for example when youth present to the ERs with
injury, accidents, or other clinical presentations, that may actually have an invisible suicide component.
The goals of this study will be realized through three different youth cohorts: 1) A nationally representative
Community Sample ages 10-24 (N=5000), will be thoroughly assessed to determine prevalence of a range of
suicidal behaviors (ideation, attempt and completion) and the presence of risk factors, using a unique blend of
quantitative and qualitative (vignettes) measures. This Cohort will also serve as comparisons/controls for the
other two Cohorts. 2) The Clinical Attempters Sample will include all identified suicide attempters (estimated
N=400), who will be assessed and compared to the Community and ER samples in a case-control design, to
uncover factors influencing trajectories of suicidal behaviors. 3) Emergency Room Sample: To uncover an
additional source of “invisible” risk factors, we will screen youth who present at the ER for ostensibly non-suicidal
reasons (N=720) and assess them in the same way as the Community and Attempter samples. The assessment
of each Cohort will be followed longitudinally in two subsequent waves. Taken together, these Cohorts, analyzed
individually, longitudinally, and in case-control comparisons, will improve understanding of suicide trajectories
and uncover the hitherto invisible risk factors for suicidal behaviors specific to developmental stages. Thus, this
investigation should generate age and context targeted prevention strategies.

Public health relevance
Rates of youth suicidal behaviors are unacceptably high and continue to rise in the US and around the world, and call out for the development of age and context-specific prevention strategies based on better defined risk factors, some of which are as yet unidentified and are thus invisible. This study aims to uncover these invisible risk factors for youth suicide by thoroughly characterizing a large community cohort of youth (n=5000) in Guyana, a country with one of the highest rates of youth suicide, and comparing them to a cohort of youth who have attempted suicide, and a cohort of youth presenting to an emergency department with complaints that, despite denial, may contain invisible suicide risk, and following these cohorts longitudinally. By repeating these assessments over time, and comparing results across these groups, we expect to be able to uncover important suicide risk factors unique to these youths’ age and circumstances, and to contribute to lowering the suicide rates among youth in Guyana, other LMICs, and the rest of the world.